Characterizing the role of adolescent physical activity in early onset breast cancer risk for women across the familial risk continuum

PROJECT SUMMARY
Early onset breast cancer (BC) incidence has increased dramatically worldwide, including in the U.S. where the
greatest increase has occurred in young non-Hispanic Black (NHB) women. Identifying the modifiable causes of
early onset BC is critical for reducing health inequities, a top priority for public health and BC prevention, and
addresses one of the NCI’s 2020 provocative questions on the etiology of cancers in adults under age 40.
Physical activity in adulthood is an established risk factor for cancer, and the long latency of tumorigenesis
suggests that physical activity in adolescence may play an important role in the development of early onset BC.
However, there is currently limited epidemiologic data, especially from racially diverse cohorts, to support this. It
is essential that we address this major gap in the evidence-base. The overarching goal of this study is to elucidate
the role of adolescent physical activity in the risk of and outcomes from early onset BC, including whether
physical activity impacts breast tissue biomarkers in adolescent girls and young women. Aim 1 (K99) will evaluate
adolescent physical activity in association with early onset BC risk and outcomes after diagnosis in young women
across the continuum of BC susceptibility using survival modeling approaches coupled with causal methods,
including Mendelian randomization and sibling set analyses. This aim will use existing data from a racially diverse
family-based cohort of 31,640 women that is enriched for BC family history (BCFH) and includes 7,703 (1,422
NHB or Hispanic) women diagnosed with BC before age 50 (3,108 diagnosed before age 40). Aim 2 (K99) will
determine if physical activity is associated with intermediate markers of BC risk in adolescent girls, including
timing of breast development and breast tissue composition (BTC) measured by optical spectroscopy (OS). This
aim will use existing prospective data from two adolescent cohorts, including a multiethnic cohort of 1,040 girls
that is enriched for BCFH and a cohort of 216 NHB and Hispanic girls in NYC. Aim 3 (R00) will evaluate if
adolescent physical activity is associated with structural and metabolic differences in the breast tissue of young
women under age 40 and determine if these alterations are associated with early onset BC risk. This aim will be
completed during the independent R00 phase by conducting a case-control study in 150 women under age 40,
newly diagnosed with BC, and 300 matched controls (sample ≥50% NHB or Hispanic). BTC will be measured in
cases and controls using OS and mammography. Taken together, this study will provide the most comprehensive
evaluation of adolescent physical activity and early onset BC to date, which is needed to move the field of BC
prevention research forward in developing novel intervention strategies for populations at increased risk of early
onset disease. This research will be complemented by experiential and didactic training in molecular and genetic
epidemiology, advanced statistical methods, physical activity research, and intervention design, as well as career
development activities. This K99/R00 award will thus facilitate the long-term career objective of leading an
independent research program studying modifiers of cancer risk that are amenable to early life intervention.

Public health relevance
PROJECT NARRATIVE The dramatic increase in early onset breast cancer (BC) incidence in the U.S., which has been most pronounced in non-Hispanic Black (NHB) women, underscores the need for an investment in cancer prevention research that is focused on risk modification beginning early in life. Increasing adolescent physical activity through community and family-based interventions may be one key factor in reducing early onset BC risk and racial disparities, but there is currently limited epidemiologic data, especially from racially diverse cohorts, to support this. This study will address this major gap by using data from racially diverse family-based cohorts that are enriched for BC susceptibility to elucidate the role of adolescent physical activity in early onset BC risk and outcomes after diagnosis in young women across the BC risk continuum and provide mechanistic insight that is needed to move this promising avenue for BC prevention and health equity forward.